Nanomaterial Radioisotope Detectors for Intracellular Measurements

The capability to analyze cellular uptake of physiological and pharmacological compounds with increasing
sensitivity and temporal resolution plays a critical role in understanding the underlying molecular pathways
involved in human diseases and disorders. Among the most challenging analytes are those present at very low
concentrations with high temporal variability, and small molecules lacking moieties amenable for optical and/or
electrochemical detection. Radioisotopes (RI) facilitate highly sensitive detection of these analytes, with minimal
perturbation of analyte mass and structure, compared to fluorescent labels and other molecular tags. β-particle
emitters, including 32P, 33P, 35S, and 3H are commonly used as biological tracers due to the prevalence of these
atoms in biological molecules.
Despite the advent of new molecular analysis approaches, RI remain the gold standard in a wide range of
quantitative biological, chemical and environmental studies. RI labels have played a critical role in the
investigation of biological systems, for almost a century. Though new analytical approaches, including mass
spectrometry, now allow sensitive detection of label-free mixtures, the high mass sensitivity of radioassays is
unparalleled, making radioassays indispensable for a range of biochemical and biomedical studies. Furthermore,
improved detection capabilities that enable a broader application of RI detection to new biomedical research
questions should prove transformational in high sensitivity biomolecular analyses.
In this SBIR application, we propose to continue development of proprietary, IP-protected, innovative core-shell
nanomaterials capable of real-time, and in some cases, molecularly selective, detection of low energy RIs directly
in aqueous samples. These nanomaterials be demonstrated for intracellular measurement of low energy RI-
labeled analytes. Such measurements would seed new research investigations and would position Scintillation
Nanotechnologies INC as the only commercial entity providing products that perform such measurements.

Public health relevance
Project Narrative – Public Health Relevance: This research project will lead to further development of a new category of radioisotope-responsive sensors that can be used for chemically selective detection of radioisotope labeled compounds in advanced bio/chemical and biological assays. The capabilities afforded by this research will play a pivotal role in disease-relevant signal transduction research, drug discovery, clinical evaluation and many other key applications.